Comparative modeling of sarcoma microenvironments for the discovery of biomarkers and tumor vulnerabilities

ABSTRACT
Soft-tissue sarcomas are heterogeneous tumors that originate from cells belonging to the
mesenchymal lineages, and that affect almost 200,000 individuals worldwide each year. The most
aggressive and metastatic sub-types in adults are those with complex karyotypes and multiple
genetic aberrations. The overall survival of these sarcoma patients has not greatly improved in
recent years, and alternative approaches to chemotherapy and radiotherapy such as
immunotherapy have so far provided only marginal benefits. Novel therapeutic advances for UPS
are hindered by the lack of knowledge about the functional consequences of the complex genomic
alterations found in patients and limited characterizations of the tumor microenvironment (TME),
which would reveal non-cell-autonomous mechanisms critical to sarcoma progression.
Experimental tools and available animal models currently do not address these limitations.
However, appropriate models could facilitate the efficient discovery of new targets and immune-
based therapies for these tumors, which have relatively low incidence and for which the
development of clinical trials is often challenging. Accordingly, we propose to generate sarcoma
mouse models that encompass the actual somatic aberrations observed in patients. Moreover,
we will use these models to facilitate studies of treatment response and TME composition. The
employment of these new models, together with newer technologies such as single-cell RNA-
sequencing (scRNA-seq), CyTOF and Imaging Mass Cytometry (IMC) will ultimately illuminate
the key expression profile of the single tumor cells, mechanisms of metastasis, resistance to
conventional treatments and TME components that may influence such mechanisms. Ultimately,
these models will translate to the clinic more effective therapeutic combinations and regimens.
Successful completion of this project will i) generate new mouse models of complex sarcoma that
recapitulate the genetic defects found in human sarcoma and provide a comprehensive functional
characterization of these models (Aim 1), ii) illuminate the expression profile of the tumor cells
and discrete sub-groups of them, to understand how these profiles influence the TME composition
(Aim 2), iii) test how these models respond to different radiotherapy administration schedules in
the heterogeneous settings of distinct tumor genetics, expression profiles and environmental
elements (Aim 3).

Public health relevance
NARRATIVE Sarcoma are metastatic and aggressive tumors, for which therapies have not improved in the last years. Novel studies have been impeded by the paucity of appropriate experimental tools and reliable mouse models. Accordingly, we propose: i) to generate and characterize novel reliable sarcoma mouse models that carry the most frequent genetic alteration found in patients ii) illuminate the expression profile of the sarcoma cells and discrete sub-clusters of them, to understand how these profiles influence the TME composition, and iii) to test how these models respond to different radiotherapy administration schedules.